A novel intrinsic pro-survival mechanism against ischemic brain injury in clinically relevant animal models

Summary
This exploratory proposal is motivated by the recent discovery of neuronal “actinification,” a pro-survival
reorganization of the neuronal actin cytoskeleton that is observed following neuronal ischemia in vitro and in
vivo. The formin protein INF2 (inverted formin 2) is the key driver of actinification. Silencing INF2 in cultured
neurons prevented actinification and increased neuronal death, while augmenting INF2 increased actinification
and reduced neuronal death. In a mouse model of small vessel ischemia, blocking formin activation
exacerbated stroke-induced neuronal cell death. However, the in vivo effects of augmenting INF2 were not
tested, due to technical limitations. The proposed project will overcome this challenge and build on the prior
work to characterize actinification in vivo using middle cerebral artery occlusion (MCAO) in mouse brain, a
model of large vessel occlusion that more closely represents clinically relevant stroke conditions. The central
premise is that INF2-dependent actin reorganization confers a temporary pro-survival advantage to neurons
undergoing ischemic stress by protecting the somatodendritic compartment from acute damage. The project
will characterize actinification in vivo using this model in young and aged adult mice (Aim 1), and will directly
test the hypothesis that gain of function of INF2 via overexpression of the INF2 gene will protect neurons from
ischemic brain injury (Aim 2).

Public health relevance
Narrative Brain ischemia, which causes acute injury to neurons, is a major cause of death and disability in patients, yet few treatment options are available to augment the current standard of care. This project uses an animal model of large vessel stroke to test a novel hypothesis on pro-survival mechanism during ischemia.